MU CENTER FOR PHYTONUTRIENT AND PHYTOCHEMICAL STUDIES

OVERALL DESCRIPTION: This application continues and amplifies the work already undergoing at the Center. The overall goal of the MU proposal is to foster interdisciplinary research that will enable the systematic evaluation of the safety and efficacy of botanicals. The PI's of the current proposal have already established collaborations, which has been shown a productive one. The proposed studies are aimed to understand the molecular mechanisms of phytochemicals and phytonutrients in human disease. The Center grant contains five projects, pilot studies, core units and career development. The concepts directing the research program include 1) the influence of phytonutrients in the progression of prostate carcinoma, this proposal examines the effect of ERKO mice will be studies in the TRAMP mouse model. 2) The effects phytoestrogens in the innate immunity of ER deficient mice, this proposal aims to determine whether phytoestrogens act to innate immunity through either the ER alpha or beta, or both, in SCID mice. 3) This project will determine whether treatment of CF cystic fibrosis with soy derived isoflavones, (primarily Genistein) acts through a non-ER-mediated pathway, on the mutated cystic fibrosis transmembrane conductance regulator (CFTR). 4) To identify and characterize botanicals with primary emphasis on those used in food supplements. 5) To examine alternative molecular mechanisms of phytoestrogens when considered as polyphenols in neurodegenerative disease. The research is facilitated by resources and several well established core facilities. The center Advisory Committee will provide guidance from distinguished representatives that will meet twice a year.